Developmental Funds

4.0 Abstract: Developmental Funds
Developmental funds support the University of Maryland Marlene and Stewart Greenebaum Comprehensive
Cancer Center's (UMGCCC's) mission by facilitating recruitment of new faculty in areas of strategic need and
by supporting pilot studies necessary to develop research so that it can compete for extramural funding.
UMGCCC has also used Cancer Center Support Grant (CCSG) pilot funds to support didactic clinical research
training for new faculty. In the last funding cycle, $701,806 in CCSG funds were invested in faculty recruitment
for the Population Science Program. In contrast, $1.8 million in pilot research funds ($373,832 from CCSG) were
allocated in the last cycle. These pilot grants resulted in $14.2 million of new extramural funding. In addition,
UMGCCC invested more than $11.3 million in funds to recruit new basic and clinical research faculty. This
funding was leveraged by an additional $24.1 million in departmental and institutional funds to support basic
science and clinical recruits who are members of UMGCCC. These recruits have significantly enhanced all five
UMGCCC research programs. In the current application, $179,000 in CCSG developmental funds are requested
to support UMGCCC investigators' pilot projects and provide preliminary data for future external funding of novel
projects. Because of a need identified as part of our strategic planning process, $148,093 per year in CCSG
developmental funding is requested to support faculty development in areas of strategic need. These funds will
be used to help newly recruited clinical research faculty complete certificate training in clinical research.
UMGCCC is committed to enhancing the clinical research capabilities of new faculty in multiple cancer
disciplines.